Neuronal exosomes to identify biomarkers and pathology of deployment-related TBI

Traumatic brain injury (TBI) is a signature injury of OIF/OEF Veterans. More than 360,000 armed service
members sustained TBI during combat and training from 2000 to 2016. There is currently no diagnostic
biological marker for TBI nor can current diagnostic tools identify individuals at greatest risk for chronic
neurological and subsequent functional impairments after TBI. Neuronally-derived exosomes (NDEs)
obtained from peripheral blood may be a powerful tool to develop accessible CNS-based biomarkers
associated with neuronal dysfunction, particularly in relation to long-term brain injury and
neurodegeneration. Our recently published work demonstrates that neuropathological proteins (e.g
betaamyloid, Aß, and tau) within NDEs can predict conversion from mild cognitive impairment to
Alzheimer's Disease (AD) while plasma levels do not. Studies of NDEs are now being tested as companion
biomarkers in AD clinical trials to help reduce screen fail rates and increased enrollment. We have recently
found that cytoskeletal and synaptic proteins are also abnormal in deployment-related TBI patients >3 mo
after TBI. Specifically, both Aß and neurogranin are altered in plasma NDEs from participants who
experienced a deployment-related TBI. Taken together, our data support the hypothesis that plasma NDEs
may be a powerful tool to identify accessible and CNS-specific protein biomarkers for TBI. NDEs are also
enriched for short length “micro” RNA (miRNA) cargo. Each miRNA can regulate protein expression from
hundreds of target messenger RNAs, providing an efficient mechanism to exert genome-wide regulation
and simultaneously affect several cellular pathways. miRNAs confer tissue specificity and have recently
emerged as potential biomarkers and therapeutic targets for neurodegeneration. Hence, identification of
CNS-specific miRNAs associated with NDEs may provide a window to the pathogenic processes in chronic
TBI for future intervention. We hypothesize that proteins related to neurodegeneration within NDEs,
such as Aß, as well as miRNAs associated with NDEs have the potential to be biomarkers of TBI and
associated symptoms. To test this hypothesis we will leverage our prospective longitudinal study of
combat deployment effects in >1200 Marines, of which 176 experienced mild/moderate deployment-related
TBI. This study collected physical and mental health, neurocognitive performance and blood samples 1 mo
before and 4-6 mo after a combat deployment to Afghanistan. We will use 150 TBI samples with 150
samples of matched controls with no TBI history to complete 2 aims. Aim 1 will examine utility of
cytoskeletal and neuronal proteins in NDEs to identify TBI in addition to persistence of post-concussive
symptoms and cognitive decline. Candidate neurodegenerative proteins include tau, Aß, neurogranin,
neurofilament light chain and calpain-cleaved αII-spectrin N-terminal fragment. Studies will also leverage
these prospective samples to examine if change in NDE proteins from pre-and post injury reflects symptom
change, providing potential causal inferences for these proteins in the pathogenic process of TBI. Aim 2 will
use an unbiased discovery approach to identify novel miRNAs associated with TBI and associated
symptoms and neurocognitive decline. Small RNA sequencing will be conducted on exosomal RNA.
miRNA associated with TBI will be validated using RT-qPCR and replicated in an independent sample set.
Top candidates will be examined for changes pre and post injury to understand the contribution of these
markers to the pathogenic process after injury. This study has strong potential to provide accessible,
quantitative biomarkers for TBI and associated symptoms, as well as identify potential functional targets for
intervention. !
!

Public health relevance
More than 360,000 armed service members sustained a TBI during combat and training from 2000 to 2016. Although a number of fluid biomarkers have emerged for detecting acute phases of TBI, biomarkers that detect persistent pathology and symptoms have been understudied. The VA is faced with treating TBI years after the initial injury, hence biomarkers associated with persistent symptoms and comorbidities are urgently needed to aid diagnosis, prognosis and development of targeted treatment strategies. Exosomes are secreted vesicles that are released from most types of cells including neurons. Neuronal exosomes are a readily detectable in blood, and are promising tools for aiding diagnosis of neurodegenerative disorders. This project will determine if circulating proteins and RNA carried in neuronal exosomes have utility as biomarkers for TBI and the associated persistent symptoms of TBI. This study will support the development of diagnostic tools for deployment-related TBI. !